Short term training for veterinary students

Project Summary
The purpose of the training program outlined in this renewal application is to provide short-term intensive research
experiences to professional veterinary medical students. The short-term goal is to stimulate an interest in the pursuit
of hypothesis-based research that examines mechanisms, treatment, and prevention of disease. The long-term
goal is to increase the number of veterinary students who embrace research as part of their career, with a focus
that ranges from basic science/discovery to translational and epidemiological studies. These individuals fill a unique
niche in the biomedical community, combining a comparative medical education with investigatory skills which are
essential to advancing human and animal health. The program is based upon a research-intensive summer
experience that is part of a larger Summer Research Program. First- and second-year veterinary students select
mentors from graduate faculty with primary appointments in Ohio State’s Colleges of Veterinary Medicine,
Medicine, Public Health, and Food, Agricultural and Environmental Sciences. Projects are developed in
collaboration between student and mentor, assuring that the project reflects student interests and ideas.
Development of the proposal and preliminary training activities occur prior to summer, and presentation and
publication of research results are emphasized in the period following summer. The latter includes an end-of-
summer research symposium, where students make oral presentations of research results, and poster/platform
presentations at the CVM Research Day the following spring. The most meritorious projects are selected by an
Executive Steering Committee based upon proposals submitted to and ranked by the CVM Council for Research.
This approach maximizes quality of students and projects, with an average of 25 applications for 10 T35 positions.
The faculty mentor: student ratio is 3.3:1, providing many training options that ensures a fit with student interests.
Summer seminars emphasize science communication, commercialization and intellectual property, and career
development. We have implemented a journal club that will now be led by a T35 co-director to reinforce concepts
in scientific rigor and reproducibility. Topics reflect the breadth of summer projects and individual sessions will
include moderation of student presentations by a faculty subject matter expert. Program success is reflected in
significant increases in the number of former T35 trainees in research-oriented careers relative to national
employment data for veterinarians, representing a greater than two-fold increase in academic, government and
industry employment. This reflects leading indicators that include graduate program enrollment (36%) and
publications emanating from research projects over the life of the program; 40% of T35-supported students publish,
and 31% of the publications are 1st authored by the student. To build upon this trajectory, the program will now
establish a formal relationship with the Career Areas of Emphasis component of the 3rd and 4th year veterinary
medical curriculum, developing a certificate program in Comparative Biomedical Research, emphasizing research
career experiences and opportunities under the guidance of an external advisory committee.

Public health relevance
Project Narrative The research experience supported by this training grant enhances recruitment of DVMs into graduate programs or other research career tracks. This translates into an increased proportion of DVMs who ultimately pursue research-oriented careers in academia, government, and industry, thereby addressing the national need for veterinary scientists who are an essential component of our biomedical research force. We will build upon this trajectory by establishing a formal relationship between the training program and a unique component of the veterinary medical curriculum at the Ohio State University: Career Areas of Emphasis.